Fast-Track Multimodal monitoring for neonatal neurocritical care

PROJECT SUMMARY
In the US, approximately 1.5M babies are admitted to the Neonatal Intensive Care Unit (NICU) each
year. Continuous monitoring of these patients is essential and the ability to quickly identify critical changes in a
patients' health status is crucial to guiding daily care and therapy. While individual medical devices are helpful
in this endeavor, integrating information from multiple devices onto one display and performing real-time
analytics on this data enhances identification of the reasons for a change in patient condition and not just that a
condition has changed. Continuously recording and providing both trending and real-time analysis for real
changes in patient status can help optimize care decisions thus improving outcomes in this fragile population.
In this grant we will build upon the success of the previously cleared Vital Sync multi-modal monitor that
captures and analyzes information from over 100 devices in the NICU to help make the information actionable.
The new device provides a continuous and retrospective view of patient condition so that care providers can
objectively evaluate the effectiveness of treatment modifications. Real time assistance with identification of
changes in patient condition helps to optimize new neuroprotective protocols. Improved review of prior patient
condition through trending analysis and event marking assists with continuity of care across shift changes. The
Phase I prototype is designed to evaluate the feasibility and usability of the tool in the NICU environment. The
phase 2 system will support additional features including reduced connectivity burden and protocol support.
Centraview 2.0 will be a platform for future modular upgrades that will enhance clinical decision support (CDS)
in any ICU environment.
Phase 1 Aim 1 – Create a prototype multimodal monitor for neonatal neurocritical care
Based on existing experience and technology, we will design and prototype a new generation bedside monitoring
system for collecting and displaying data from the key NICU medical devices at UFHealth.
Phase 1 Aim 2 – Evaluate usability of the new system in a simulated NICU
In a simulated NICU environment, we will create three neonatal patient scenarios and evaluate the system in a
usability study with 8 NICU clinicians including surveys to determine perceived value, usability, and acceptance.
Phase 2 Aim 1 – Expand connectivity, add protocol adherence, and enhance usability
Clinical feedback from a successful Phase 1 will be used to improve the functionality and usability of CentraView
2. HIE protocol support will be added to the system along with several other new features including derived
parameters and wireless data collection.
Phase 2 – Aim 2 – Evaluate the effectiveness of CentraView 2 Clinical Assistant
We will first collect baseline data for 6 months at UFHealth to measure adherence with several clinical practice
guidelines (CPG). Next, we will install and train clinicians on the use of the CentraView system and determine if
the system improves compliance with the CPGs.

Public health relevance
PROJECT NARRATIVE Neonatologists provide life-supporting care to babies born with difficult health conditions. In this proposal we will build an electronic tool to improve the quality of care and patient safety for these very fragile patients. Improved care is realized by providing a variety of clinical decision support tools to clinicians including: a continuous searchable stream of relevant data, smart thresholds and alarms, protocol support, shift-change hand-off support, and improved information visualization utilities that highlight critical changes in patient condition.